Administration

Mayo Clinic Cancer Center Administration's function is to facilitate the mission of the Mayo Clinic Cancer Center (MCCC) in providing administrative management end centralized services that support the Center Director, Senior Leadership, Program Leaders, Shared Resource Directors end members of the Cancer Center. Cancer Center Administration (CCA) actively participates in the planning, implementation and evaluation of programmatic and shared resource activities across MCCC's three campuses. CCA also provides administrative leadership for key MCCC initiatives including efforts to bolster minority accrual to clinical trials, address health disparities, enhance integration and optimize resource utilization and performance. Specific CCA responsibilities include: • Shared Resource oversight; • Coordinate faculty recruitment and retention; • Management of Center membership process; • Coordination of internal funding opportunities; • Space management; • Coordination of MCCC Committees; • Financial management; • CCSG Application process management; • Information Systems management; • Oversight of MCCC communications strategies; • Cooperative Group support end liaison.